IU Clinical Center: Drug Induced Liver Injury Network

PROJECT SUMMARY/ABSTRACT
Established in 2003, the DILIN currently has 6 clinical centers and one data coordinating center and is recruiting
eligible patients with well-defined idiosyncratic DILI into two ongoing multicenter prospective studies. Indiana
University is one of the founding clinical centers and has robustly participated in all DILIN operations since its
inception. The RFA DK-22-013 was issued to address several new objectives with regards to its risk factors,
causality, clinical features and natural history, and potential therapies. We propose the following specific aims to
meet the goals of this RFA. Specific Aim # 1: To enroll large number of eligible adults with suspected DILI into
ongoing DILIN prospective, acute liver injury, and retrospective studies. We propose to collect prospective and
retrospective cases of suspected DILI from multiple sources in Central Indiana, each providing distinctive
epidemiological facets and research potential. We propose to utilize the medical informatics and health
information exchange infrastructure established by the Regenstrief Institute for Health Care. A special focus of
this aim is to robustly enroll the following subpopulations with intense focus on racial and ethnic diverse patients
with suspected DILI. Specific Aim # 2: To conduct two distinct ancillary studies, each one adding significantly
to our understanding of DILI. These include: (a) To test the hypothesis that plasma whole transcriptome cell-free
mRNA serves as an important approach to better understand the mechanisms, phenotypic presentation, and
outcomes of patients with suspected DILI. We will conduct plasma cf-mRNA RNA-Seq profiling of patients with
suspected acute DILI at baseline and during follow-up to delineate cf-mRNA signatures associated with acute
DILI and its phenotypes and outcomes. (b) To test the hypothesis that HLA variants are associated with DILI due
to selected agents. This objective builds on successful investigations conducted by DILIN during the current
funding period. Specific Aim # 3: DILI carries considerable mortality and morbidity but there is no treatment
available other than withdrawing the offending agent. To address this unmet therapeutic need, we propose to
conduct a randomized, double-blind, placebo-controlled pilot study of saroglitazar, a novel PPARα/γ agonist in
individuals with well characterized cholestatic DILI meeting predefined eligibility criteria. Our hypothesis is that
saroglitazar, a potent PPARα agonist attenuates cholestasis and improves recovery of patients with cholestatic
DILI. Sixty individuals with definite, highly likely or probable DILI with R<2 and total bilirubin > 3 mg/dL will be
randomized to receive either saroglitazar (1 mg once daily) or placebo for 4 weeks. Primary efficacy endpoint is
normalization of serum alkaline phosphatase after 4 weeks of intervention. Specific Aim # 4: The objective is to
robustly participate in all cross-consortia activities including participating and leading (where appropriate)
steering committee, genetics committee, ancillary studies committee, publications and presentations committee,
causality committee, and herbal and dietary supplements (HDS) committee activities.

Public health relevance
Project Narrative Drug induced liver injury (DILI) is a rare but serious problem that can lead to liver failure, transplantation, death, or chronic liver disease. Drug induced liver injury network (DILIN) was set up by the National Institutes of Health in 2003 to facilitate clinical, mechanistic and therapeutic research related to DILI. Indiana University is proposing several novel specific aims to promote DILIN during the next funding period.